Expanded Double Negative T cells in SLE.

Systemic lupus erythematosus afflicts 1 to 2 million Americans and is associated with significant
morbidity and mortality. While wiser use of immunosuppressive drugs and prompt treatment of
complications have improved the overall survival and quality of life, we still lack specific drugs,
full understanding of the involved pathogenic processes and valuable disease biomarkers. In
addition, our understanding of local, organ-specific mechanisms involved in the execution of
tissue injury is limited. An expanded population of T cells missing CD4 and CD8 from the
surface (double negative T cells) in the peripheral blood of patients with systemic lupus
erythematosus, helps autologous B cells to produce immunoglobulin and dsDNA antibodies,
produces the proinflammatory interleukin 17 and invades tissues to cause inflammation. This
application proposes the use of state-of-the-art new technologies including spectral cytometry,
single cell RNA sequencing and series of novel engineered mice to study the diversity of the
double negative T cell population in the peripheral blood and kidneys of lupus-prone mice and
people with systemic lupus erythematosus and understand how an inflammatory environment
contributes to their generation. In parallel, experiments are proposed to understand how
inflammatory cytokines act on kidney resident cells to enable the establishment of inflammation.
The proposed experiments will inform the development of approaches to suppress the
generation of pathogenic double negative T cells and prevent the establishment of tissue
inflammation.

Public health relevance
Narrative Systemic lupus erythematosus afflicts young women and is frequently devastating. We now understand that the disease is heterogenous and we need to understand better the diverse mechanisms that are involved in the expression of the disease. In this proposal we plan to understand how an expanded subpopulation of lymphocytes known, as double negative T cells, contributes to the expression of the disease. The gained knowledge will enable the consideration of effective individualized treatment of patients.